Identification of drug-targetable IFN-stimulated genes mediating immune activation during ART-treated HIV-1 infection

ABSTRACT
Antiretroviral therapy (ART) fundamentally altered the lives of people living with HIV-1 by shifting the
disease course from rapid progression to AIDS and death to a manageable chronic disease. However, ART-
treated people still experience higher rates of morbidity and mortality than the general population. As more
people are treated with ART and the HIV-1 treated population ages we need new strategies to normalize their
life span and quality of life. Therefore, research is needed to elucidate the biological processes underying the
heightened risk of morbidity and mortality and to translate this knowledge into new treatments.
This proposal seeks to evaluate how immune activation during HIV-1 infection contributes to increased
mortality and morbidity, and how this knowledge can be translated into novel treatments. Following all viral
infections, acute immune responses are critical for reducing virus levels. Subsequently, those responses are
turned off. In HIV-1 infection, however, heightend immune activation persists even after virus levels are reduced
to very low levels by ART—those immune responses are never turned off. Over time, persistant activation
exhausts the immune system, clearing the way for more viral replication, opportunistic infections and AIDS.
One contributing factor to chronic immune activation during HIV-1 is that expression of IFN stimulated genes
(ISGs) is persistently up-regulated. Humans carry hundreds of ISGs with many functions including direct
antiviral activity and regulation of other ISGs and immune responses. Our group has documented that ISG
levels are persistently increased during HIV-1 infection. We hypothesize that targeting specific ISGs may be a
strategy for reducing chronic immune activation during HIV-1 infection while allowing other compontents of the
immune response to remain effective.
The objective of this proposal is to identify ISGs contributing to chronic immune activation during HIV-1
infection and to translate those data into a ranked list of existing drugs that could repurposed as adjunctive
treatments with ART. To do so, we will measure ISG expression among HIV-1 infected indivuals before and
after initiation of ART, and will compare their ISG expression levels to uninfected participants. Among the HIV-
1 infected participants, we will also determine how ISG expression relates to clinical HIV-1 parameters and
immunologic markers. In order to more clearly define the role of ART on ISG expression we will also conduct
in vitro studies in which we directly treat cells from HIV-1 infected individuals with ART and compare ISG
expression before and after treatment. These studies will provide detailed information about the effects of ART
use on ISG levels and immune activation by reducing viral replication and direct effects of the drugs themselves.
Finally, we will integrate data from our studies of ART and ISG expression with data regarding gene expression
during other infections and drugs that can be used to treat those other infections. By doing so, we aim to identify
drugs that can be repurposed to treate chronic immune activation during HIV-1 infection.

Public health relevance
PROJECT NARRATIVE Although combination antiretroviral therapy (cART) drastically improves life expectancies of people living with HIV-1, cART-treated individuals still experience higher rates of morbidity and mortality than the general population. One contributor to this increased risk is that immune responses are chronically activated and eventually lead to immune exhaustion and AIDS. The proposed project seeks to understand the role of interferon stimulated genes (ISGs) in this process and to identify existing drugs that could be repurposed for reducing HIV- 1-associated immune activation.